Community and Stakeholder Partnerships

PROJECT SUMMARY
Stark racial inequities in maternal and infant morbidity and mortality continue in Allegheny
County, PA, although many adverse events are preventable. One path to improve reproductive
health equity among Black birthing people is through an expansion of community-partnered and
community-centered research, training, education, and engagement. The Community
Component of the EMBRACE (Equity Maternal and Birthing Outcomes and Reproductive
Health through Community Engagement) Center of Excellence will implement a strengths-
based community engagement strategy to promote bi-directional and process-driven learning,
research, education, and training in perinatal and maternal research in Allegheny County, PA.
Through intentional integration of interdisciplinary community collaborators in all aspects of the
research lifecycle; training and education opportunities; knowledge generation and skill-sharing;
and dissemination and implementation of research findings, the Community Component will
leverage existing networks to advance coordinated efforts of research and community agencies
that are invested in maternal health. The Community Component will work closely alongside
EMBRACE Research Projects and the Training Component to ensure equal and equitable
practices throughout, utilizing reproductive health equity and health justice frameworks,
approaches, and best-practices for Black-centered and community-engaged work. As a result,
the Community Component will serve as a trusted hub within EMBRACE for individuals and
agencies to build community, capacity, and infrastructure for advancing Black maternal health
and eliminating racial maternal health disparities in Allegheny County.

Public health relevance
PROJECT NARRATIVE The Community Component of the EMBRACE (Equity in Maternal and Birthing Outcomes and Reproductive Health through Community Engagement) Center of Excellence will leverage existing networks to advance coordinated efforts of research and community agencies that are invested in maternal and child health through a strengths-based community-centered engagement strategy to promote bi-directional and process-driven learning, research, education, and training. The Community Component will work closely alongside EMBRACE Research Projects and Training Component to ensure equal and equitable practices through intentional integration of interdisciplinary community collaborators in all aspects of the research lifecycle; training and education opportunities; knowledge generation and skill-sharing; and dissemination and implementation of research findings. The Community Component will serve as trusted hub within EMBRACE for individuals and agencies to build community, capacity, and infrastructure for advancing Black maternal and child health and eliminating racial maternal health disparities in Allegheny County.